Administration and Coordination Core

Project Summary
For our program we propose an administrative structure that centers on the board of 6 PIs. The board is
chaired by Gaudenz Danuser in a first-among-equals mode. The PI board will make all decisions for the
program – science, policies, budget, personnel, outreach – based on consensus-seeking. All 6 PIs have long-
standing scientific relations in various configurations. In the unexpected case that consensus building fails, the
PI board will be able to seek guidance by the External Advisory Board.
Charged by the PI board, Danuser will be responsible to implement activities that enable efficient team science
(Aim 1), resource sharing with the community (Aim 2), and outreach (Aim 3). Key activities include:
 Organization of a team meeting structure enabling optimal collaboration with appropriate
communication channels;
 Implementing policies on sharing data and authorship that foster unrestricted team science;
 Formation and engagement with an advisory board that will scientifically inspire and help with the
mitigation of challenges that may arise in a team science project;
 Provision of infrastructure for dissemination of hardware, software and reagents;
 Organization of a workshop for small groups of microscopy core facility managers with the goals of
gaining over early adopters of the program technology while training the trainers;
 Organization of pilot grants within the UTSW cancer research community to interact with the program;
 Organization of a visitor program targeting cancer biologists and cell biologists at research institutions
with large URM populations;
 Organization of two scientific workshops.
Danuser will be assisted by the administrative team of the Lyda Hill Department of Bioinformatics and Cecil H.
and Ida Green Center for Molecular Systems Biology he chairs at UT Southwestern Medical Center.